Improving dermatology access by direct-to-patient teledermatology and computer-assisted diagnosis

Background: Access to dermatology remains a significant problem in the Department of Veterans Affairs
(VA), particularly during the COVD-19 pandemic. To address this need, VA will deploy an asynchronous
teledermatology mobile app-My VA Images-which allows new dermatology patients to securely submit history
and photos of their skin for evaluation. The app may also eventually provide a conduit for patients to submit
skin images at will for analysis and triage by artificial intelligence (AI)-powered computer vision to a
dermatologist.
Significance: This project addresses the following gaps: 1) The impact of direct-to-patient teledermatology on
access to dermatology and on the satisfaction with such care by both patients and health care providers has
not been systematically studied; 2) Currently no AI-powered computer vision tool has been developed and
validated for patient-generated images; 3) The readiness of large healthcare organizations, such as VA, and
their stakeholders to engage in direct-to-patient teledermatology and AI is unknown.
Innovation and Impact: Two related innovations will be tested: 1) Direct-to-patient teledermatology for new
patients and 2) Evaluation of patient-submitted skin images by AI-powered computer vision. These separately
have the potential to transform remote access to expert skin care in VA and together are potentially synergistic.
At the conclusion of the project, we anticipate having a systematic understanding of how direct-to-patient
technologies perform and of the operational gaps that will need to be addressed by VA before these
technologies can be implemented enterprise-wide. The goal is to establish a critical scholarly and operational
foundation to safely move toward a transformative vision where Veterans will no longer be tied to a fixed time
and place for care, but instead will have the choice of self-directed, convenient and rapid access to expert-level
dermatology care wherever and whenever they need it.
Specific Aims: 1. Assess the impact of direct-to-patient teledermatology on access and health system
utilization. 2. Assess, refine and augment computer-assisted evaluation of patient-submitted images.
3. Assess readiness of VA and Veterans' acceptance to implement direct-to-patient care.
Methodology: Aim 1 will use a Type I hybrid pragmatic study design to compare the impact of the direct-to-
patient teledermatology intervention relative to usual in-person and usual consultative teledermatology
referrals, measuring access chiefly by data from VA's Central Data Warehouse. Aims 1 and 3 will measure
patient satisfaction and readiness for change using survey instruments and interviews. Aim 2 will include both
testing, training and refinement of the AI-powered computer vision and measure concordance with
dermatologists. Population: Veterans referred to Dermatology at three VA medical facilities. Intervention:
Eligible and medically appropriate patients will be offered the option to submit history and images to
Dermatology using the My VA Images app. Comparison: The intervention will be compared to usual care (in-
person and consultative teledermatology) groups. We will also compare two AI-powered computer vision
models with dermatologist diagnoses. Outcomes over a 5-year period: 1) Multiple measures of temporal and
geographic access to dermatologic care; 2) Patient satisfaction; 3) Concordance of AI with dermatologist
diagnoses; 4) Organizational and patient-readiness for remote and computer-assisted dermatologic care; and
5) Implementation and sustainability of the direct-to-new patient teledermatology process.
Next Steps/Implementation: Successful completion of the project will provide VA’s Office of Connected Care
and other offices tasked with enhancing access to specialty care with critical data that will justify further
expansion of the direct-to-patient asynchronous teledermatology program. The project will also provide VA
with critical data to evaluate the role of AI-powered computer vision in future remote care strategies.

Public health relevance
Veterans must often wait and travel significant distances to receive care from a VA dermatologist. Emerging innovative technologies promise to allow VA to deliver expert skin care to Veterans wherever and whenever they need it. By moving Veterans’ images and histories instead of people, skin concerns can be more rapidly diagnosed and managed remotely by a dermatologist or eventually by a computer trained by artificial intelligence methods. This project will implement a VA-developed teledermatology mobile application at three VA facilities and measure its ability to deliver dermatologic care directly to Veterans in a timely and travel- minimizing manner, and patient and VA staff satisfaction with the process. In parallel, the project will use the data that Veteran patients submit to train and refine artificial intelligence-powered computer vision models whose performance will be tested against dermatologists. The readiness of Veterans and VA to implement these technologies will also be evaluated.